Retrovirus Models of Cancer

OVERALL PROJECT SUMMARY
This competitive renewal application (P01CA100730) seeks funds to continue our highly integrated studies of
retrovirus models to elucidate cellular mechanisms of lymphocyte transformation and associated
lymphoproliferative disease. Infection of CD4+ T-cells with the human retrovirus, human T-cell leukemia virus
type 1 (HTLV-1), induces their immortalization and enables those cells to accumulate genetic mutations leading
to the lymphoproliferative malignancy, adult T-cell leukemia lymphoma (ATLL). The advantage of the HTLV-1
model to study leukemogenesis is the rapid induction of T-cell immortalization brought about by the viral infection.
This model of leukemogenesis allows careful examination of the biologic changes and response patterns of virus
infected preneoplastic cells while under the influence of cellular and viral factors that control and perhaps
promote progression to cancer. In the previous funding period we made substantial advances in our
understanding of: 1) how the HTLV-1 transforming gene, hbz, contributes to cell immortalization; 2) how
chromatin insulator, CTCF, controls HTLV-1 gene expression and pathogenesis; 3) and how HTLV-1 infected
cells contribute to bone destruction through production of extracellular vesicles; and 4) how ATLL can be targeted
for anticancer therapy and HTLV-1 infection prevented by an envelope mRNA vaccine. In the next funding period,
the overall theme of the Program Project is to continue our studies with the HTLV-1 lymphoproliferative disease
model with a focus on discovering how key viral, cellular and microenvironmental factors work in concert to
promote T-cell malignancy. We now recognize three interrelated areas of study that are major gaps in our
understanding of the pathogenesis of HTLV-1-associated T-cell leukemogenesis: 1) Immune correlates of
prevention and treatment with envelope and hbz vaccines; 2) The effect of HTLV-1 chromatin insulators on T-
cell immortalization, reactivation from latency, and contribution to the transition to and progression of ATLL, and;
3) Bone microenvironmental factors that contribute to the survival and expansion of HTLV-1-infected T-cells and
their progression to ATLL.

Public health relevance
OVERALL PROJRECT NARRATIVE The ultimate goal of this Program Project Grant (P01) competitive renewal application is to utilize the human T- cell leukemia virus type 1 (HTLV-1) T-cell immortalization model to gain understanding of the microenvironmental, cellular and viral factors that lead to progression to leukemia and lymphoma, and with this knowledge, to identify unique targets for diagnosis and treatment of HTLV-1 infection and adult T-cell leukemia-lymphoma (ATLL) and related lymphoproliferative malignancies.